Implementing best practices in software design for Network Level Analysis

PROJECT SUMMARY
Contemporary research views the brain as a large-scale, complex network composed of nonadjacent, yet
connected brain regions. Rather than focusing on a limited set of a priori regions of interest, the field of
neuroimaging has shifted towards statistical testing on associations across the whole connectome, i.e., at every
possible brain connection. However, these connectome-wide association studies have a severe multiple
comparisons problem, necessitating statistical methods which can control the false positive rate for associations
between behavior and upwards of 50k functional connections. The long-term goal of the Parent BRAIN Initiative
R00 (EB029343, ‘Innovative biostatistical approaches to network level analyses of connectome-behavior
relationships’) is to create a statistical analysis software that would leverage the inherent network architecture of
the connectome in order to probe fundamental biological mechanisms underlying the development of healthy
and disordered cognition, behavior, and emotion. Specifically, the parent grant aims to formalize and validate in
house analysis pipelines into a Network Level Analysis (NLA) toolbox as a comprehensive, versatile tool for use
in connectome-wide association studies. While the research focus of this career transition award is on the
application of NLA to developmental mechanisms of executive function and emotion regulation, this versatile
analytic tool will be transformative to connectome data analysis across species, across the lifespan, and in health
and disease. As part of tool development during the K99/R00, Dr. Wheelock has validated multiple NLA
approaches, establishing sensitivity and specificity of network level findings using in silico connectome-behavior
relationships, test-retest reliability of NLA approaches using in vivo human connectome and behavioral data from
the HCP-Young Adult cohort, and ongoing work is extending NLA to investigate changes in connectome
architecture supporting the development of executive and emotional function using connectome and behavioral
data from the ABCD study (N=11,000 age 9-14). In Aim 2 of the R00, NLA toolbox is being updated to reflect
object-oriented programming, incorporating longitudinal models and a graphical user interface. The goal of this
Administrative Supplement is to improve NLA functionality by implementing several crucial changes. Specifically,
funding from this Administrative Supplement, NOT-OD-23-073, will promote refactorization of NLA to improve
computational efficiency, and usability by both developers and end users. The goals of this Supplement are to
1) refactor and optimize computational modeling in lower-level programming languages, 2) incorporate error
logging and expand documentation, and 3) establish unit and integration testing to improve code merging.
Successful completion of these Aims will both complement and extend the impact of the Parent R00, significantly
improving the functionality and sustainability of NLA software in keeping with best practices of open science as
well as increase accessibility of the software, enabling community-wide adoption of network-analysis methods
for connectome-wide association studies.

Public health relevance
PROJECT NARRATIVE While we have been developing Network Level Analysis software to address aims of the parent R00, this Supplement in response to NOT-OD-23-073 will provide an opportunity to refactor and improve the software to better support the growing worldwide neuroimaging community. These refactoring activities will reduce the computational time needed to complete longitudinal and nested analysis of connectome data and the incorporation of error logging and online documentation will increase usability. The completion of these aims will significantly improve the functionality and sustainability of Network Level Analysis software and increase accessibility of the software, enabling community-wide adoption of network-analysis methods for connectome- wide association studies.